Penn State Roybal Center for Promoting Adherence to Behavior Change and Enhancing Cognitive Function

PROJECT SUMMARY – ADMINISTRATIVE CORE
The goal of the Administrative Core for the Penn State Roybal Center is to accelerate the translation of basic
research on mechanisms of adherence to behavior change into principle-based potent and scalable
interventions that increase adherence to physical activity and enhance cognitive function after an intervention.
The Administrative Core will provide management oversight and oversee communication activities that involve
our research team, NIH representatives, and the broader research community. The Core will also engage in
financial oversight and planning and ensure regulatory compliance with the Office of Research Protections and
any ancillary review processes. Administration and support of the pilot program to extend the Center’s impact
across institutions will operate through the Administrative Core. And finally, the core will initiate strategic
planning activities that anticipate, shape, and respond to emerging priorities at the NIH and in the broader
scientific community. These activities are reflected in five specific aims. First, the Core will support clinical trials
by monitoring and reporting on timely progress, fidelity, quality, and effectiveness of scientific and fiscal
operations. Second, the Core will lead a robust targeted pilot grant program, including organizing review
panels, with consultation from Center leaders and the External Advisory Committee. Third, the Core will
expand the reach of Center activities in strategic science communication and collaboration opportunities with
industry leaders, non-profit organizations, external research institutions and government agencies. Fourth, the
Core will convene and coordinate an External Advisory Committee to provide feedback to the Director on
scientific and administrative decisions. Finally, the Core will coordinate communication among team members,
meetings, and travel to annual Roybal Center network meetings organized by the coordinating center and
funder. By drawing on best practices for soliciting, reviewing, and managing pilot studies, the Administrative
Core will ensure that the pilot grant program is structured, transparent, and effective in identifying innovative
projects with high potential for impact. These efforts aim to lay the foundation for a large national trial to
validate physical activity as a preventive strategy for Alzheimer's Disease and related dementias (AD/ADRD).